Spanish Productivity in the Assessment of Spanish-English Bilingual Children

Project Summary/Abstract
There are approximately 5 million school-aged bilinguals in the United States, and 75% of these bilinguals
speak Spanish at home (National Center for Education Statistics, 2018). Despite this prevalence, there is a
lack of language assessment tools for children who speak more than one language. This lack of tools results in
incomplete assessment protocols that do not characterize children’s language abilities in their home language.
Thus, bilingual children do not receive appropriate intervention for communication disorders like developmental
language disorder (DLD), which affects their long-term quality of life (Conti-Ramsden et al., 2013). One
potential solution is the involvement of caregivers in the assessment process, who provide unique insights into
children’s language in a variety of contexts and may provide much needed information in the home language
(Restrepo, 1998). However, these assessment protocols have focused on accuracy-based measures, which
may not capture young children’s emerging morphosyntactic development (Rispoli et al., 2009). One promising
language assessment tool is grammatical productivity, which assesses children’s breadth and depth of
grammatical structures during language sampling to derive a productivity score (Hadley & Short, 2005). This
measure has been shown to differentiate typically developing English-speaking monolingual children from their
peers with DLD (Gladfelter & Leonard, 2013). The limited research available on productivity in Spanish-English
bilingual children has shown that the productivity of English grammatical structures yield group differences
between typically developing peers and those with low language abilities (Potapova et al., 2018). However,
children’s grammatical productivity has not yet been examined in Spanish, and this is necessary to fully
characterize Spanish-English bilingual children’s language ability. To address this gap, this project will develop
a Spanish grammatical productivity measure from the language samples of Spanish-English bilingual children
(Aim 1) and evaluate the use of Spanish grammatical productivity in caregiver reports through a culturally
adaptive framework (Aim 2). We will accomplish this by first determining which Spanish grammatical structures
would best contribute to a productivity measure from the language samples of Spanish-English bilingual
children, a subset of which have DLD. Mirroring similar strategies employed in the development of English
productivity (Hadley & Short, 2005), we will compare typically developing children’s productive use of Spanish
grammatical structures to that of children with DLD, and compare children’s Spanish productivity across ages.
Critically, we will also examine how our Spanish productivity measure may be adapted for use by Spanish-
speaking caregivers of bilingual children through a culturally adaptive framework, thus assessing the cultural
validity of this process. In sum, this work—grounded in a disorder within diversity framework (Oetting, 2018)—
will assess approaches to measuring bilinguals’ home language and ultimately reduce health disparities in this
population.

Public health relevance
Narrative Spanish speakers represent approximately 75% of all children learning two languages in the United States, yet there is a lack of tools to assess the home language of these bilingual children. The proposed project will develop a Spanish grammatical productivity measure to capture the emerging language abilities of young bilingual children (Aim 1) and evaluate the use of this Spanish measure in the reports of caregivers through a culturally adaptative framework (Aim 2). The results of this project will improve language assessment by informing how bilingual children, with and without a language disorder, produce Spanish grammar, and how caregiver reports on grammatical productivity can be used to characterize bilingual children’s language development.